Olfactory memory acquisition consolidation and recall

Though a neuron must be able to respond reliably to stimulation, it is equally important that it alters its response as a function of specific experiences. The molecular and cellular basis for this plasticity and how stimulus-specific changes in plasticity occurs is important to understand as it underlies both normal processes such as learning and memory as well as the disease states of addiction and depression. Our goal is to use the olfactory response of the genetically tractable nematode C. elegans to determine whether a small RNA regulatory path way directs stimulus-specific neuronal plasticity. One means by which repeated stimulation alters neuronal responsiveness is via the changes in transcription elicited by epigenetic marks such as DNA methylation and histone modification (reviewed in1). In S. pombe, plants and Drosophila, chromatin marks have been shown to be directed by small RNAs2. These epigenetic changes are thought to regulate important developmental processes. Whether small RNAs can dynamically regulate epigenetic changes in neurons as a consequence of specific behaviors has not been examined. An attractive but completely untested hypothesis is that small RNAs might provide the guidance and specificity for epigenetic events that direct long-lasting changes in neuronal activity. As a first step to wards testing this hypothesis, we asked whether genes required for RNA-interference (RNAi) might be required for neuronal plasticity in the anatomically simple but genetically powerful model organism, C. elegans. C. elegans is inherently attracted to specific odors which it senses using G-protein coupled receptors (GPCRs), however, its attraction is dampened if the odors are not accompanied by food. We term this experience-dependent dampening of the response to odor olfactory adaptation. The key “s witch” that turns on olfactory adaptation is the entry of the cGMP-dependent protein kinase (PKG), EGL-4 into the nucleus of the odor-stimulated sensory olfactory neuron AWC (Lee et al., submitted). In our preliminary studies, found that a specific class of small RNAs work with a gene encoding a chromatin associated protein, HPL-2, (a histone H3 lysine 9 tri-methyl binding protein) within the sensory neuron at the time of odor-exposure to promote adaptation. Both factors act downstream of EGL-4 nuclear entry and both factors act in the same genetic pathway for adaptation. Thus, our studies have raised the novel and exciting possibility that environmental stimuli can act via small RNAs to direct changes in chromatin. We propose to test this hypothesis by determining whether small RNAs and chromatin are central players in the adaptation process, how they function in adaptation and whether they can regulate transcription of candidate targets in response to prolonged odor-exposure. The significance of this work is that large scale epigenetic changes of the sort we are studying are found in models for addiction and depression3,4. In the models of depression, these changes occur in the context of prolonged GPCR stimulation. How these changes occur, is unknown. Understanding the molecular details of the pathways by which neuronal stimulation is translated into chromatin marks is key to understanding these diseases.

Public health relevance
Project narrative This project's aim is to understand how the newly discovered small RNA molecules work in the adult neuron as it responds to its ever-changing environment. We would like to know if they allow neurons to remain changeable. It is this changeability in response to new in put that allows neurons to function. If they loose this plasticity or responsiveness, they are prone to degeneration. In fact, neurons in the brain of animals that are addicted to opiate type of drugs have lost their ability to respond properly; they have lost their plasticity. Thus, understanding how neurons remain plastic and responsive in the face of stimulation may shed light on both how neurons degenerate and how they loose responsiveness in the context of addiction. The role of small RNAs is just emerging from our work. We hope that understanding what these small yet potent RNA molecules are doing in neurons will lead to better understanding and perhaps intervention into both neurodegeneration and addiction.